EFFECT OF ETOMOXIR ON GLUCOSE AND LIPID METABOLISM IN DIABETICS

The purpose of this study is to examine the effect of Etomoxir on glucose and lipid metabolism in diabetic subjects. Etomoxir inhibits the enzyme carnitine palmityl transferase I and has been shown to be effective in lowering glucose levels in diabetic animals.